MYCOPLASMA PNEUMONIA &CHLAMYDIA AS ETIOLOGIC AGENTS OF COUGH IN

The purpose of this study is to determine the role of two bacteria, Mycoplasma pneumonia and Chlamydia pneumoniae, as causes of respiratory illness in adolescents and adults.